Resource Sharing Core

ABSTRACT
The resource sharing core of the proposed ROBIN U54 center project will consist of experienced faculties in
the Department of Radiation Oncology at the University of Maryland and Department of Pathology at Cornell
University. A long history of collaboration already exists between the members of this Core and investigators
on the main projects. The Core will provide centralized and cost-effective support to the projects by providing a
wide range of data needed for the projects, including multi-omics, imaging, and dosimetry data in radiation
oncology. The core service provides a crucial way to coordinate data collection, storage, and sharing to ensure
data from the main projects are analyzed consistently and efficiently. There are three specific aims for this
core: Aim 1. Provide state-of-the-art methods for multi-omics data analysis and storage to project researchers.
The core research team has extensive experience in the wide array of genome-wide analyses that are
planned, and it will therefore provide all necessary expertise for the correct and efficient pre-processing and
analysis of the multi-omics data generated within each project across the U54 ROBIN center. Sharing the
multi-omics data within the U54 ROBIN Center will leverage the Cloud Data Warehouse at Cornell, which
enables the research use of integrated data from multiple clinical systems and analytical platforms. Aim 2:
Develop tools and infrastructure for extraction, analysis, and storage of imaging and dosimetry data in radiation
therapy. We will develop tools and databases for extracting, analyzing, and storing the data that are unique for
radiation therapy, including both imaging data (CT, MRI, PET and CBCT) and dosimetry data (3D dose
distribution, dose volume histogram for target and organs at risk). We will also develop techniques for image
quality enhancement as well as radiomics analysis on both imaging and dosimetry data. A graphical user
interface (GUI) will be developed to facilitate the extraction and analysis of the multi-dimensional data. Aim 3.
Provide cloud-based platforms and infrastructures for resource sharing across institutions. The cloud-based
Data Warehouse will be used to store and share multi-omics data at Cornell University, while the cloud-based
Flywheel software will be used to store and share imaging and dosimetry data at the University of Maryland.
The database systems will be interfaced with other electronic data systems, and procedures will be instituted to
ensure data quality, integrity, and confidentiality. The systems will be implemented to enable inter-project
collaborations and those with external collaborators in the future. The data and tools will be made publically
available with transparency under a fee-based service model. In summary, the resource sharing core will have
an integral role in the scientific development, execution, and analysis of all projects. Core investigators are
committed to working closely with project PIs and investigators to assess any issues that may adversely affect
resource sharing and implement all necessary changes as the projects progress.